Shellfish Safety Assistance Project

Project Abstract
The Interstate Shellfish Sanitation Conference (ISSC) adopts uniform procedures, incorporated
into the National Shellfish Sanitation Program (NSSP), and implemented by all shellfish control
authorities. The ISSC gives state shellfish programs, current and comprehensive sanitation
guidelines to regulate the harvesting, processing, and shipping of shellfish. The Biennial
Meeting provides a forum for shellfish control authorities, the shellfish industry, and academic
community to resolve major issues concerning shellfish sanitation.
_____________________________________________________________________________________________
Interstate Shellfish Sanitation Conference Project Abstract --- Page 1 of 1

Public health relevance
Project Narrative This project will enhance both the effectiveness and uniformity of the National Molluscan Shellfish Safety Program by improving the flow of information between federal and state regulatory agencies, industry, and consumers. The project will strengthen state activities by providing assistance in such areas as procedural and policy guidance, technical training, research, consumer education, and conformity with requirements of the National Shellfish Sanitation Program (NSSP) Model Ordinance. The project provides for research opportunities related to shellfish safety which is used by state authorities to assist in the development and implementation of effective biotoxin management and Vibrio risk control plans for implementation by states and industry that area consistent with current science, epidemiology, and HACCP based food safety measures. _____________________________________________________________________________________________ Appendix A Grant Application RFA-FD-11-023 Page 1 of 1